Lipid Trafficking and Metabolism in the Retinal Pigment Epithelium

SUMMARY: Age-related macular degeneration (AMD) is marked by retinal pigment epithelial (RPE) lipid dys-
homeostasis, including pathologic extracellular lipid accumulation, impaired mitochondrial lipid metabolism, and
increased lipid peroxidation, a toxic form of lipid oxidative damage. The RPE normally plays an essential role in
retinal lipid homeostasis, consuming and secreting prodigious amounts of lipid. Lipid consumption comes in the
form of a large daily lipid load, including both lipoprotein uptake from the choroid and phagocytosis of lipid-rich
photoreceptor outer segments (OS). Some of this lipid is oxidatively metabolized in the mitochondria, producing
metabolites that energetically support photoreceptors. Lipid oxidative metabolism also minimizes glucose use
by the RPE, allowing glucose to pass unused from the choroid to highly glycolytic photoreceptors. Lipid secretion
is primarily through lipoprotein, some of which supports regeneration of OS and some of which accumulates as
the extracellular deposits typical of AMD. A characteristic of cells facing large lipid loads is the formation of lipid
droplets (LD), intracellular lipid storage organelles that dynamically regulate lipid trafficking, metabolism, and
lipid peroxidation. Specific LD function varies widely between different cell types. RPE LD have been studied in
the context of visual cycle biology, but their physiology and role in maintaining non-retinoid lipid homeostasis in
the RPE is essentially unexplored. This proposal examines the composition, physiology, and role of LD in human
RPE lipid homeostasis. The over-arching hypothesis is two-fold: a) LD can temporarily store a wide-range of
lipids derived from the RPE’s daily lipid load, preventing their lipid peroxidation; and b) lipid released from LD by
specific enzymes is preferentially metabolized in mitochondria rather than secreted. By facilitating lipid oxidative
metabolism over lipid secretion, RPE LD may enhance metabolic support for photoreceptors and decrease the
accumulation of pathologic extracellular lipid seen in AMD. To test the hypothesis, various lipid loads will be fed
to primary- and induced pluripotent stem cell (iPSC)-derived human RPE cultures, with LD composition assessed
by mass spectrometry. The fate of lipids released from LD will be tracked via microscopy, biochemical methods,
and lipidomics. The principal investigator’s long-term goal is to develop the expertise to define intracellular RPE
lipid trafficking pathways that enhance RPE lipid homeostasis and decrease pathologic extracellular lipid
deposition, opening up new therapeutic avenues for AMD. To achieve this goal, the principal investigator’s
career development plan (CDP) focuses on RPE lipid biology, establishing expertise in iPSC-RPE culture,
radiolabeled lipid tracing, high-resolution microscopy, bio-energetic profiling, and lipidomics. The CDP’s
mentorship team takes advantage of deep expertise in lipid biology and lipidomics at University of Michigan and
has a track-record of successfully mentoring K awardees to research independence. The combination of
didactics and hands-on experience in this proposal ensures the investigator will become a successful AMD-
focused clinician with an independent basic science program harnessing RPE lipid biology to understand AMD.

Public health relevance
PROJECT NARRATIVE: Degeneration of the retinal pigment epithelium (RPE) underlies age-related macular degeneration (AMD), the leading cause of irreversible vision loss in the developed world. Avenues to improve RPE function in the dry form of AMD are desperately needed, as the disease currently has no FDA-approved treatments. Here, we explore the role of a lipid storage organelle, termed a lipid droplet, in maintaining the RPE’s health and function, with implications for developing novel therapeutics for dry AMD.